OXYGEN THERAPY FOR MODERATELY SEVERE RETINOPATHY OF PREMATURITY

To determine if supplemental therapeutic oxygen will reduce the proportion of infants with pre-threshold ROP that advance to Threshold ROP. Also, to determine the impact of this treatment on rates of growth, pulmonary status, and length of hospital stay.